Utilizing Technology and AI Approaches to Facilitate Independence and Resilience in Older Adults

Abstract
Dementia research has focused almost exclusively on the deleterious aspects of AD, including memory
loss, cerebral atrophy, and the molecular consequences of Aβ/tau pathology. Unfortunately, despite
advances in our understanding of AD, the toolbox of viable treatments is no greater today than 20 years
ago. An astonishing, yet underappreciated, aspect of AD/ADRD is the moment-to-moment fluctuation in
cognitive health. Cognitive fluctuations, defined as spontaneous alterations in attention, arousal, and
cognition, are evaluated based on the occurrence of symptoms such as impaired consciousness or
confusion. However, the exact features and causes of cognitive fluctuations are still unclear. A greater
understanding of the factors that lead to cognitive fluctuations and the precise behaviors that are
present would allow us to identify strategies for preventing and managing dementia symptoms. We plan
to provide a robust framework for quantifying cognitive fluctuations and lucid intervals in individuals
with Alzheimer’s disease (AD) using a mobile technology platform applied within one’s home or local
environment. Psychometric test results collected using a diagnostic app will be integrated with caregiver
reports of cognitive changes to determine the features and incidence of these moments in AD patients
(Aim 1). We then aim to identify reliable predictors of cognitive fluctuations and lucid intervals using
wearable health sensors to uncover data-driven patterns of cognitive change (Aim 2). This three-dimensional view of cognition (in-home cognitive testing, caregiver reports, health sensors) will provide
unprecedented insight into the nature of cognitive decline, cognitive fluctuations, and potentially
incidences of lucidity.

Public health relevance
Public Relevance The contribution of this project will be a greater understanding of the features, incidence, and predictability of lucidity in dementia and insights into the underlying neurobiology. This is significant because it will inform attempts to trigger lucidity on demand using behavioral and therapeutic interventions to enhance the frequency, duration, and strength of lucid intervals in AD patients.